Friend or Foe? The AMPK Signaling Pathway During Developmental Myelination

Myelination is a highly energy-intensive process. Despite this, how oligodendroglial cells regulate energy production and
usage remains poorly understood. A candidate regulator of oligodendroglial energetics is AMPK, a Ser/Thr kinase that both
responds to cell energy levels and regulates energy production, thus acting as a metabolic sensor. AMPK is activated
endogenously when ATP levels dip, for instance in fasting or exercise, but AMPK activity can also be manipulated
pharmacologically, for instance using the diabetes drug metformin. In adult mice, metformin has recently been found to
both activate oligodendroglial AMPK and enhance remyelination following myelin damage , whereas in aged mice, which
typically show limited myelin repair, metformin causes an even more pronounced increase in remyelination. These studies
have led to the prediction that metformin is a desirable candidate for the treatment of demyelinating diseases, and several
clinical trials are now underway for MS. However, our preliminary studies suggest that AMPK activation via metformin
treatment during postnatal development may delay or suppress myelination. And, despite the growing interest in metformin
and other AMPK activators in neurological diseases, AMPK’s ability to regulate oligodendroglial dynamics and myelination
during development remains unresolved. For instance, a mouse knockout of the AMPK regulatory subunit in neural stem
cells led to profound alterations in neural progenitor cell proliferation and neural cell survival, with the resulting brains
being substantially smaller and severely hypomyelinated. However, given the gross alterations to overall brain development,
it was not clear whether AMPK loss in oligodendroglia themselves contributed to the hypomyelination. In this proposal we
test the hypothesis that regulated oligodendroglial AMPK signaling is essential for correctly timed myelination, and will
assess the prediction that enhanced AMPK signaling during the high metabolic demand of developmental myelination will
suppress myelination. In Aim 1, mice will be treated with metformin during distinct temporal windows spanning early, mid,
and late developmental myelination, followed by an assessment of the steps in oligodendrocyte development (OPC
proliferation, survival differentiation) necessary for appropriate myelination and of the resulting myelin itself. In Aim 2,
conditional knockout mice, AMPKα1f/fl; PDGFRα-Cre mice that lack the predominant AMPK catalytic subunit, will be
used to determine the role of AMPK in oligodendrocyte lineage dynamics and myelination, as in Aim 1. In Aim 3, isolated
mouse OPCs and oligodendrocytes will be used to determine transcriptome differences in response to metformin (AMPK
activation) or in AMPKα1f/fl; PDGFRα-Cre+ cells (AMPK LOF), followed by pathway analysis. These studies will fill the
knowledge gap on the role of AMPK in oligodendrocyte development and myelination, as well as investigate the
translational impact of metformin on developmental myelination.

Public health relevance
PROJECT NARRATIVE Myelination, a crucial aspect of brain development, occurs prominently during childhood and extends through the mid-20s in humans. Abnormal myelination has been linked to autism, ADHD, and OCD. Metformin, a diabetes drug, has been found to promote myelin repair and rejuvenate the aged cells responsible for myelin production. However, despite its FDA approval for individuals over the age of 10 and ongoing clinical trials involving younger children, there is a gap in research on metformin’s impact on early myelin development. This proposal aims to investigate metformin-regulated signaling pathways and their influence on early developmental myelination in mice, with hopes of providing insights into its safety for use in children.